Diffuse Optical Tomography for Identifying Early Complicationsof Aneurysmal Subarachnoid Hemorrhage

PROJECT SUMMARY/ABSTRACT
Aneurysmal subarachnoid hemorrhage (aSAH) carries a mortality rate greater than 30%. For patients who
survive the initial hemorrhage, their clinical course is fraught with complications including hydrocephalus,
seizures, cerebral edema, vasospasm, and delayed cerebral ischemia. Clinical monitoring of aSAH patients,
however, is often confounded by altered mental status and inability to fully participate in the bedside
neurological exam, potentially impeding the early diagnosis of post-hemorrhagic complications. The ability to
identify early biomarkers of neurological complications after aSAH would be an important advance in
the current standard of care of aSAH patients.
In the long-term, aSAH survivors suffer from cognitive deficits that have been correlated with alterations in
functional connectivity (FC). Changes in FC occur rapidly after SAH in animal models and may reflect acute
injury, but it remains unknown if FC changes correlate with acute neurological decline in humans subjects.
Additionally, cortical spreading depolarization (CSD) has also been implicated as an etiology of neurological
complications after aSAH. CSD is a wave of tissue depolarization that massively alters ion gradients,
contributes to excitotoxicity and cerebral edema, and affects local vasculature. Using invasive subdural
electrodes, CSD’s have been observed in aSAH patients, and clusters of CSD events correlate with delayed
ischemic infarctions. However, noninvasive detection of CSD does not exist.
This proposal will utilize high density diffuse optical tomography (DOT) to monitor aSAH patients to test the
hypotheses that CSD and changes in resting state FC can predict neurological decline. DOT measures
changes in light absorption of oxy- and deoxy-hemoglobin. DOT has been used to monitor resting state FC in
stroke patients and can be used to detect CSD. One advantage of DOT as a monitoring method is that it can
be used at the bedside in the ICU and used for longitudinal investigation, unlike MRI-based methods which are
limited to discrete imaging epochs and are not easily accessible to critically ill patients. Aim 1 will test the
hypothesis that neurological deterioration correlates with a changes in resting state FC. Aim 2 will test
whether CSD after aSAH correlates with acute worsening of the neurologic exam.
The results of this project will establish if FC alterations and CSD events after aSAH can serve as biomarkers
for neurological decline in aSAH patients. The long-term implications of such biomarkers include earlier
interventions and treatments of aSAH complications, such as blocking CSD with ketamine or vagal nerve
stimulation, and/or using FC changes to guide rehabilitation. Additionally, noninvasive detection of CSD with
DOT would provide a breakthrough method to study CSD in other neurological conditions.

Public health relevance
PROJECT NARRATIVE Aneurysmal subarachnoid hemorrhage (aSAH) is the most lethal type of stroke due to its severe and life- threatening complications that can develop rapidly. Changes in functional connectivity and/or cortical spreading depolarization (CSD) may herald these complications and could serve as useful biomarkers for impending neurological decline. In this proposal, the application of high density diffuse optical tomography to monitor CSD and resting state functional connectivity after aSAH will provide a novel clinical strategy for early identification of neurological complications and offer a groundbreaking method to study CSD in other neurological diseases, since noninvasive detection methods for CSD do not currently exist.